The development of adaptive specificity in learning and memory

PROJECT SUMMARY
Many forms of psychopathology that emerge or peak in prevalence in adolescence, including anxiety and
depression, are associated with overgenerality in value-based learning and episodic memory. Understanding
developmental change in the specificity of value-based learning computations and memory representations may
provide insight into periods of heightened risk for the onset of psychopathology. Critically, to effectively guide
behavior across diverse contexts, learning and memory systems should flexibly adapt to the environment,
representing information more generally when the reward statistics of similar states converge and with a higher
degree of granularity when more detailed representations are needed to guide behavior. In adulthood,
interactions between the hippocampus and medial prefrontal cortex support both specific representations of
individual exemplars as well as more abstract representations that guide generalization during learning. While
prior studies of value-based learning and episodic memory suggest that children represent information with less
specificity than adults, no research has examined how the cognitive and neural mechanisms that support the
flexible adaptation of value-learning computations and memory representations to the demands of varied
contexts change over development. The proposed work will use a novel reinforcement learning task, coupled
with advanced computational modeling and neuroimaging methods, to address this question. Specific Aim 1 will
examine age-related change in context-invariant biases toward more specific or more general value associations
during learning, as well as in their flexibility to adapt to the reward statistics of different contexts. Specific Aim 2
will probe how the specificity of value-learning associations influences the specificity of memory for information
encountered during learning, both immediately and over time. Finally, Specific Aim 3 will examine how the reward
statistics of the learning environment influence the granularity of representations within the hippocampus and
medial prefrontal cortex across development. We hypothesize that normative learning and memory development
may be marked both by increases in the specificity of neurocognitive representations that emerge across
contexts, and in their flexibility to adapt to the reward statistics of varied learning environments. The proposed
work will elucidate the mechanistic relations between specificity in value-based learning and in memory across
development, enhancing our understanding of potential neurocognitive risk factors for the emergence of
psychopathological symptoms associated with overgeneralization.

Public health relevance
PROJECT NARRATIVE Multiple forms of psychopathology that emerge in childhood and adolescence — including depression and anxiety — are associated with overgenerality in learning and memory processes. The studies proposed here examine developmental changes in how the specificity of value-learning computations and episodic memory representations flexibly adapt to effectively guide behavior across varied learning environments. By combining computational modeling with functional neuroimaging, this work will elucidate mechanistic relations between adaptive specificity in value-based learning and episodic memory across development.